Exploiting cross-reactive, conserved epitopes in Plasmodium vivax to develop a vaccine against falciparum placental malaria.

PROJECT SUMMARY/ABSTRACT
A vaccine is urgently needed to protect pregnant women from malaria infection and the devastating effects
of this disease on maternal and child health. Two vaccines are in early stage clinical trials and both target
domains within the protein VAR2CSA, which is the major surface antigen expressed by Plasmodium
falciparum placental isolates. This protein binds to receptors in the placenta and mediates sequestration of
infected red blood cells (iRBCs), underpinning the pathogenesis of placental malaria. However, VAR2CSA
is under strong immune selection and is highly polymorphic; this compromises vaccine efficacy by limiting
the breadth of protection against diverse alleles. Polymorphic antigens present a ubiquitous challenge in the
development of malaria subunit vaccines. The long-term goal of this project is to develop an alternative
approach to a vaccine against pregnancy-associated malaria that targets highly conserved, subdominant
(even cryptic) epitopes. What is unique about this approach is that it exploits a mechanism of cross-
species immunity, where epitopes from one Plasmodium species elicit robust, broadly neutralizing
antibodies against structurally related antigens from another species. This mechanism was discovered
recently in Colombian and Brazilian populations where VAR2CSA antibodies can be acquired outside of
pregnancy following infection with P. vivax, and these antibodies blocked sequestration of iRBCs using in
vitro correlates of placental malaria. The cross-reactive epitope in P. vivax was mapped to subdomain (SD1)
in PvDBP and human SD1-purified antibodies blocked parasite adhesion. The objective of this project is to
develop a vaccine to protect pregnant women from falciparum placental malaria that is based on the cross-
reactive epitope in vivax SD1. This will be achieved through synthesis of three complementary Specific
Aims. Epitopes required to elicit functional, cross-reactive antibodies will be identified in Aim 1 through
conformationally constricted peptide microarrays screened with mouse monoclonal antibodies (mAbs) and
human mAbs to SD1 isolated from Colombian study populations. Epitopes will be synthesized as peptide-
conjugates or within engineered recombinant domains, and immunogenicity will be optimized in Aim 2 to
produce antibodies with functional activity against parasites that express diverse alleles of var2csa. In the
third Aim, the cryptic epitopes in VAR2CSA recognized by these antibodies will be mapped to identify the
targets of antibodies elicited by an SD1-derived vaccine. The integration of these findings will provide
important insight into the mechanism of cross-species epitope recognition, which will serve as the basis for
a vivax vaccine against falciparum placental malaria and could be applied more broadly to vaccines against
other malaria antigens.

Public health relevance
PROJECT NARRATIVE Malaria in pregnancy is a major public health issue that risks the lives of mothers and their babies. Our project will explore a novel vaccine approach to prevent poor outcomes of falciparum malaria in pregnancy that is based on conserved targets of heterologous immunity between malaria species. We will define the immune mechanism that mediates cross-protection and develop these conserved epitopes as vaccine candidates.